Characterization of novel pyrazole compounds with potent anti-cancer activity

Breast cancer is the most frequently diagnosed tumor type and a common cause of cancer-related
deaths in women worldwide. In the US, African American (AA) and Hispanic/Latina women exhibit a
higher proportion of Triple Negative Breast Cancer (TNBC) than White or Asian women. In addition,
AA women have a higher risk of dying from, and being diagnosed with TNBC. Since TNBC is an
aggressive subtype with no available molecular targets and lack of immunotherapy, we have focused
our recent drug screens to identify compounds that are cytotoxic against these cells. Using a live-cell
imaging screening assay developed by my group, we recently screened 4,600 novel compounds from
the Chembridge DIVERset drug-like library of compounds on the MDA-MB-231 TNBC line and
detected fifteen compounds with significant cytotoxic activity against these cells. The most potent of
the compounds (a pyrazole-3-carbohydrazyde named P3C) was subsequently evaluated on additional
cancer cell lines and found to be cytotoxic to most cancer cell lines. A recent search for structural
analogues of P3C resulted in the identification of a compound (P3C.1) with stronger anti-cancer
activity than the original. Although P3C and P3C.1 have similar cytotoxic activity on a variety of cancer
cell lines, they also differ in activity on a small subset of cell lines. Our data indicate that they both
induce apoptosis via increased reactive oxygen species, mitochondrial depolarization, caspase
activation, cell membrane disruption, and DNA fragmentation. However, our preliminary results
indicate that the pyrazoles activate distinct signal transduction pathways. Our central hypothesis is
that the identified pyrazoles induce apoptosis via distinct pathways. Therefore, the main objective of
this project is to determine the mode of action (MOA) of each compound by comparing their gene
expression profiles and effects on key signal transduction pathways. Understanding the MOA of these
compounds is critical when testing compounds in clinical trials and in drug combination therapy. In
addition, an important goal of this proposal is to determine if the compounds reduce/inhibit tumor
progression in mice implanted with human tumors with the hope of eventually translating this basic
research into effective anticancer therapeutics that can help reduce cancer health disparities.

Public health relevance
We recently discovered two similar anti-cancer compounds with potent toxic activity against many types of human cancer cells. In this proposal, we will perform the requisite experiments to determine how the compounds cause death and if they are able to kill human cancers growing in mice. We expect that in the near future, the identified anti- cancer drugs will result in therapeutic agents that can be used alone or in combination with other FDA approved drugs for the treatment of human cancer and help reduce cancer health disparities.